STUDY OF CEREBRAL ELECTRICAL ACTIVITY ASSOCIATED WITH ISCHEMIA

A study of electrical activity, how it is affected by ischemia and edema, and how recovery of activity is related to temporary ischemic insults of graded durations. During this period, instrumentation has been procured and or constructed, optimized and familiarized. Preliminary experiments have begun.